Role of KMT2D in neurodevelopmental disorders

PROJECT SUMMARY
The proposed research and training program aims to equip the PI with the skills to become an independent
investigator and to advance the understanding of neurodevelopmental disorders (NDDs) while developing
innovative therapies. Building on previous training in epigenomics, the PI will use emerging single-cell
epigenomic technologies to link pathogenic variants in chromatin regulators to specific neuronal phenotypes.
NDDs affect more than 3 million people in the U.S., impairing language, learning, motor skills, and neurological
function. Despite their prevalence, the molecular mechanisms underlying these disorders are not well
understood, hindering the development of effective treatments. Mutations in chromatin regulators, such as
KMT2D, are major contributors to NDDs, including intellectual disability, autism spectrum disorder and
schizophrenia. KMT2D is essential for differentiation and development by modulating chromatin accessibility
and 3D chromatin structure. Loss-of-function mutations in KMT2D are associated with brain malformations,
memory defects and neuronal differentiation problems, with Kabuki syndrome being a notable example.
However, the precise molecular mechanisms by which KMT2D haploinsufficiency leads to brain abnormalities
and cognitive impairment are not well understood. This project will use mouse and human models of KMT2D
haploinsufficiency to profile single cell chromatin accessibility and 3D chromatin structure, and examine the
impact on regulatory programs in different cell types. The research and training will be guided by a
distinguished mentoring team of experts in several relevant fields: Drs. Walsh (neurobiology), Bodamer
(NDDs), Lee (single cell genomics), and Gussoni (stem cells). The results of the project will advance our
understanding of chromatin regulators in NDDs and provide broadly applicable methods and tools for other
NDDs.

Public health relevance
Project Narrative Mutations in chromatin regulators cause neurodevelopmental disorders, highlighting the need to understand the underlying mechanisms for effective treatment strategies. This project focuses on investigating the role of KMT2D, a key chromatin regulator, in neurodevelopmental disorders using new techniques such as single-cell epigenomics. The results of this research have the potential to inform new therapeutic approaches, and the methodologies employed can be extended to study other neurological disorders.